A Novel Role of Fragile-X Mental Retardation Protein in Mitochondrial Calcium Homeostasis

Fragile X syndrome (FXS) is the most prevalent form of inherited intellectual disability and the primary genetic
cause of autism. FXS is caused by loss of expression of the Fmr1 gene encoding Fragile X Mental Retardation
Protein (FMRP), a protein with RNA-binding activity thought to act primarily as a translational regulator. In
addition to intellectual disability, FXS patients present behavioral and cognitive symptoms, irregular physical
features, and metabolic symptoms. The prevailing hypothesis of FXS pathogenesis posits FMRP as a
promiscuous RNA-binding protein targeting hundreds of brain RNAs, with altered translation of these mRNA
targets as the underlying cause of the synaptic and neural circuit defects and behavioral phenotypes seen in
FXS. However, the recent clinical failures of treatment strategies targeting some of the key translational
substrates of FMRP, and the current lack of effective treatment option for FXS, argue that investigations of new
biological function of FMPR and new pathogenic mechanisms of FXS are warranted.
Mitochondria are dynamic and complex organelles with essential roles in many aspects of biology, from
energy production and intermediary metabolism to intracellular signaling and apoptosis. These broad functions
position mitochondrion as a central player in human health. In neurons, mitochondria and synapses are intimately
linked. In addition to their central role in bioenergetics, mitochondria are also critically important for maintaining
cellular Ca2+ homeostasis. Ca2+ uptake by mitochondria helps buffer cytosolic Ca2+ transients arising from
neuronal activation, protecting against the detrimental effects of Ca2+ influx. The ER-mitochondria contact site
(ERMCS) are increasingly appreciated as key structures regulating mito-Ca2+ homeostasis, and there is an
emerging role of altered ERMCS and mito-Ca2+ in the pathogenesis of neurodegenerative diseases. Whether
ERMCS and its role in mito-Ca2+ homeostasis is affected in major neuropsychiatric diseases such as FXS is not
known. The goal of this proposal is to test the central hypothesis that FMRP acts physically at ERMCS to direct
Ca2+ signaling between organelles, and that defects in this process contribute to the etiology of FXS. To test this
hypothesis, we propose to achieve the following Specific Aims in this exploratory project: Aim 1. Examine defects
in ERMCS formation in the Drosophila dFmr1 model and FXS patient-derived models. Aim 2. Test the
physiological roles of ERMCS proteins that direct mito-Ca2+ homeostasis in mediating FMRP function. By
providing evidence for the involvement of ERMCS and mito-Ca2+ in mediating FMRP function at the organellar,
synaptic, and organismal levels, these studies will lay the foundation for future mechanistic studies on the
regulation and function of FMRP in normal synaptic and neuronal processes underlying brain function, cognition,
emotion, and social behavior. Results from this study promise to significantly advance our understanding of the
fundamental roles of mitochondria and Ca2+ signaling in FXS and various related mental disorders and offer
novel and rational strategies to deliver health care for patients suffering from these devastating mental illnesses.

Public health relevance
Fragile X syndrome (FXS) is the most prevalent form of inherited intellectual disability and the primary genetic cause of autism due to loss of expression of the Fmr1 gene encoding Fragile X Mental Retardation Protein (FMRP). The biological function of FMPR and the pathogenic mechanisms of FXS remain poorly understood and no effect treatment is currently available. This project will test a previously unrecognized function of FMRP in regulating mitochondrial homeostasis through direct protein-protein interaction with ER-mitochondria contact site (ERMCS) components, with important implications for our understanding of the pathobiology of FXS and development of new therapeutic strategies to treat this devastating mental illness.